Cancer System Epidemiology Insights and Future Opportunities

TO COORDINATE THE SUBMISSION, PEER REVIEW, PRODUCTION AND PROMOTION OF A COLLECTION OF ARTICLES ON CANCER SYSTEM EPIDEMIOLOGY INSIGHTS AND FUTURE OPPORTUNITIES